Core A - Administrative Core

SUMMARY OF WORK: Core A – Administrative Core Administrative organizations, grants management, travel for advisory board, scheduling of data meetings.

Public health relevance
PROJECT NARRATIVE: Core A – Administrative Core The Administrative Core will be headed by Dr. Rockman who serves as the overall Program Director of this PPG. An important aspect of this administrative component is assurance of the overall quality of research within the Program Project. While Dr. Rockman is the administrative PI, he is one of the Project Leaders who will equally share the responsibility of data quality control with the other Leaders of this PPG.